Endothelial Glycocalyx Disintegrity: Repairing the Damage caused by Trauma-Hemorrhage

PROJECT SUMMARY/ABSTRACT
The aim of this R35 application is to develop a high quality, translational research program in inflammation-
induced endothelial damage and organ dysfunction. Dysregulation of microvascular function contributes to the
pathophysiology of indirect organ injury after trauma. In particular, damage to the endothelial glycocalyx occurs
within minutes of traumatic injury and is associated with increased microvascular permeability resulting in multi-
organ failure and increased mortality. Strategies that attenuate glycocalyx disintegrity by preventing its cleavage
and/or facilitating its repair hold significant promise for minimizing microvascular dysfunction and post-traumatic
organ injury. The long-term objective of our research program is to establish basic science and translational
studies that focus on the identification of novel therapeutic targets that will (1) prevent glycocalyx damage, (2)
repair glycocalyx integrity or (3) inhibit dysregulation of endothelial cell permeability that occurs as a result of
glycocalyx disintegrity. The specific programmatic areas of focus will include studies to identify the role of
heparanase in regulating glycocalyx (dis)integrity after trauma-hemorrhage and on mechanisms that mediate
glycocalyx synthesis. Additionally, our proposed studies will identify signaling pathways that regulate endothelial
barrier function that are effected by loss of cell surface glycosaminoglycans, heparan sulfate and hyaluronic acid,
which are primary constituents of the glycocalyx layer. Our research program will focus on the endothelial cell-
specific response to trauma-hemorrhage in organ systems that are most susceptible to secondary injury (e.g.,
kidney, lung and intestines) with the over-arching goal of determining how resuscitation strategies mediate
glycocalyx-dependent mechanisms in each organ. These programmatic areas of research hold promise for
significantly impacting the current resuscitation paradigm for patients in hemorrhagic shock by aiding in the
discovery of novel therapeutic targets that can be used to inhibit glycocalyx dysfunction, facilitate its repair or
reverse the downstream consequences of glycocalyx disintegrity.

Public health relevance
PROJECT NARRATIVE Trauma is a leading cause of death worldwide. A large proportion of trauma-related deaths that occur in the days to weeks following injury are caused by multi-organ failure that is driven by loss of microvascular barrier function. The proposed studies will support innovative programmatic areas of research to advance our understanding of the pathophysiologic mechanisms of trauma-induced endothelial damage that will guide the identification of novel therapeutic targets after injury.